NEURAXIAL AAVS TARGETING DRG CHANNELS INVOLVED IN CHRONIC POST INFLAMMATORY PAIN

ABSTRACT
Current therapeutics, including the biologics, improve management of arthritic joints but often do not adequately
address associated pain, suggesting multiple mechanisms. Delivery of antibodies/immune complexes in serum
from a K/BxN mouse to a normal mouse yields a persistent, but reversible joint inflammation accompanied by
early onset pain that persists long after resolution of inflammation. In the inflammatory phase, allodynia and the
conditioned place preference respond to anti-inflammatory drugs and drugs that block spinal sensitization, while
in the post-inflammatory phase, the pain phenotype responds to only to the latter agents. This profile is
accompanied by changes in joint innervation, DRG and dorsal horn biology, revealing a transition over weeks in
both sexes from an inflammatory to a polyneuropathic pain phenotype. The origin of this ongoing traffic and the
appearance of a post-inflammatory pain phase in the preclinical rodent model reflects a major change in the
phenotypic expression of channels and receptors within the DRG. Among the changes generated by
inflammation and nerve injury are concurrent, time-variant, increases in nociceptive afferent expression of
sodium channels (e.g., NaV 1.3,1.7,1.8,1.9) and down regulation of potassium channels (e.g., Kv1.4), changes
which yield increased afferent excitability and ectopic activity. Here we will utilize the CRISPR-dCas9 system
coupled with transcriptional activation domains or transcriptional repression domains to enable either activation
or repression of the above genes epigenetically to systematically study their roles in modulating pain states. We
have already extensively characterized the efficacy, duration, and safety profiles of epigenetic repression of
NaV1.7 in DRG primary afferents via intrathecal (IT) AAV9 (CRISPR)-dCas9 delivery. Our work has shown, in
vitro and in vivo after intrathecal delivery, titer dependent reduction in DRG NaV1.7 mRNA and allodynia in
murine inflammatory and polyneuropathic pain models. We propose now, using this IT AAV CRISPR-dCas9
epigenome modifying platform to focus in male and female K/BxN mice on the inflammatory and poly-neuropathic
joint pain component of repressing DRG NaV 1.3, 1.7,1.8,1.9 and increasing expression of Kv 1.4-channels. We
will characterize these modifications in K/BxN and K/BxN- IT AAV9 (CRISPR)-dCas9 treated male and female
mice on i) DRG target expression using RNA seq/RNA-FISH; ii) K/BxN driven allodynia / aversiveness (using
conditioned place preference); iii) adverse event profile; iv) ectopic activity and membrane excitability (patch
clamping) in primary DRG neuronal cell cultures and v) in vivo basal and evoked afferent substance P release.
These aims provide mechanistic insights into the role of. these DRG-afferent channel populations in the
inflammatory and post inflammatory arthritic pain phenotype accounting for the ongoing and evoked pain
phenotype. These insights into regulation of multiple DRG channels will also guide improved engineering of
potential therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Arthritic pain often persists after the resolution of inflammation, yielding a chronic state in which the sensory neuron displays increases in at least four sodium channels and a decrease in at least one potassium channel, yielding a polyneuropathy. To advance our thinking that management of this early inflammation and late polyneuropathy pain state is optimized by addressing changes in not only one channel but several, we will use spinal delivery of the CRISPR-dCas9 platform to epigenetically regulate these channels, a strategy with clear implication for safely managing the chronic pain in the arthritic patient.